Robust Sequence-defined Nanocages with Protein-mimetic Cavities

PROJECT SUMMARY/ABSTRACT
Mimicking protein-like cavities and functions requires to precisely organize surface groups on well-defined,
porous scaffolds to function in a concerted and orchestrated manner. Here, we propose to generate fully
sequence-defined robust nanocages for selective, multivalent recognition and catalysis reminiscent of protein
cavities. Building on the PI’s unique interdisciplinary expertise in supramolecular, organic, and computational
chemistry, the primary objective is to create strategies to design and synthesize fully sequence-defined
nanocages as artificial receptors for sensing biomolecules (e.g., enkephalins in the brain) and as selective
artificial enzymes (e.g., for site-selective modification of peptides). We will direct the positioning of the endohedral
functional groups (e.g., mono-, di-, or tripeptides) with chiral, sequence-defined covalent templates (e.g.,
sequence-defined peptide dendrimers and a-helical peptides), which will transfer their outer amino acids onto
the endohedral sites of the nanocages in a stereocontrolled manner. The Schneebeli lab has synthesized and
characterized robust, hydrazone-linked nanocages required to bulid the sequence-defined nanocages. These
nanocages have been successfully applied as receptors for small molecules, and as size-selective
polymerization catalysts, which lays the foundation for the proposed selective neuropeptide recognition and site-
selective catalysis. We will pursue two parallel avenues to create the fully sequence defined nanocages. In
Project 1, we will template nanocage formation directly in a sequence-defined manner, assembling the
nanocages with hydrazone bonds (which are reversible under acidic conditions) and then cut out the templates.
In Project 2, we will stereoselectively functionalize preformed [8+12]-nanocages (created with a novel,
cyclotrimerization-based synthesis) with the help of a-helical peptide templates and equilibrating imine bonds,
and then reduce the imine bonds and cut out the templates. This research is novel in the concept, synthetic
approach, characterization, and applications, because (i) fully sequence-defined asymmetric nanocages
represent a considerable shift in the current research of artificial molecular receptors and artificial enzymes, (ii)
hydrazone-linked nanocages and cyclotrimerization-based nanocages syntheses (pioneered in the Schneebeli
group) are powerful approaches to access large and chemically-robust nanocage frameworks capable of holding
up to 12 endohedral functional groups with full sequence definition, and (iii) the creation of robust, protein-mimetic
cavities may ultimately yield numerous advances in both fundamental structural and mechanistic knowledge of
artificial receptor/artificial enzyme design. The proposed research is significant, because it will enable synthetic
chemists to independently control the endohedral sites of porous nanocages, ultimately offering new
opportunities and approaches to rapidly sense biomolecules and catalyze new, stereoselective chemical
reactions for therapeutics development.

Public health relevance
PROJECT NARRATIVE Manmade nanocages to mimic protein cavities can be useful for medical research, as they can recognize important biological targets for sensing and catalyze reactions to synthesize therapeutics. This work proposes to create some of the first fully sequenced-defined nanocages with protein-mimetic, robust cavities, thus providing new solutions in fields of sensing and catalysis. Ultimately, this work will lead to selective, rapid sensing devices for neuropeptides to help elucidate the etiology of a variety of brain disorders, as well as to new artificial enzymes useful to synthesize otherwise difficult to access therapeutic agents.